Cancer Research Career Enhancement and Related Activities

Cancer Research Career Enhancement & Related Activities
ABSTRACT
The SKCC has a longstanding history in cancer education and training since inception in 1991. The
Associate Director for Education, Jeffrey Benovic, PhD, and doctoral program leaders drive SKCC
education activities with the support of SKCC-funded education coordinators under Dr. Benovic’s direction
and oversight by the SKCC Training Committee. The overall goal of SKCC efforts is to create an integrated
and innovative cancer research career enhancement program, which focuses on creating a pipeline of
activities to develop the next generation of cancer researchers, and to provide career training and
mentorship to those that are beginning their careers in cancer research. Specific programmatic activities are
formulated around groups including underrepresented minority high school and undergraduate students,
pre-doctoral and postdoctoral trainees, researchers, and clinicians. Development of these individuals
enhances the depth, breadth, and impact of SKCC programs and fosters a well-defined, cohesive pipeline
for cancer center member development. Current cancer-relevant activities include pre-doctoral and
postdoctoral training, cross-training in cancer research, clinical research conferences, cancer focused
seminar series, diversity training, career development activities, and extensive education and training
activities within all SKCC Programs and Shared Resources. SKCC early career investigators also benefit
from significant institutional support for cancer education and training activities and a large number of grants
that support over 50 SKCC trainees.
Development of a robust cancer research career development training pipeline, mentored development of
junior faculty, and ongoing education and training of cancer researchers across the research spectrum is a
fundamental goal of SKCC and consortium partners. We have identified and begun to implement several
new initiatives to address underdeveloped areas and build strength in areas based on a review of progress
against goals. These mechanisms include: 1) Cancer Research Data Club; 2) Trainee-only seminar series;
3) Quarterly workshop for trainees; 4) Annual Education Retreat; and 5) Funding opportunities for travel to
cancer-focused meetings.